UW SPECT/CT Acquisition

PROJECT SUMMARY/ABSTRACT The objective of this proposal is to purchase a state-of-the-art high resolution microSPECT/CT small animal imaging scanner for the University of Wisconsin Small Animal Imaging and Radiotherapy Facility (SAIRF), which will function as a long-term shared resource for NIH-funded investigators at the UW School of Medicine and Public Health (UW SMPH). Specific aims include: Aim 1: To improve the productivity of small animal imaging research at the UW SMPH by making a state-of-the-art microSPECT/CT scanner accessible to federally-funded investigators, Aim 2: To enhance the ability of these investigators to perform ultra-high resolution SPECT and CT scanning to determine cancer treatment efficacy, biological basis of disease and using-imaging based dosimetry to provide more accurate radiotherapy dosing, and Aim 3: To foster the development of new small animal imaging resources that efficiently use the personnel and shared facility resources at the UW SMPH and UWCCC. The SAIRF provides support to faculty and trainees working on small animal imaging research projects. The laboratory offers high-quality multimodality image acquisition and analyses and consultative services on a fee-for-service basis available to the campus community and beyond. The only two unmet needs currently existing within the SAIRF are the lack of SPECT imaging in general and ultra-high resolution whole animal computed tomography (CT) scanning. Acquisition of the MILabs high resolution hybrid SPECT/CT small animal scanner overcomes both of these current limitations. This application proposes to purchase a MILabs U- SPECT6CTUHR with the highest available SPECT resolution mated with 4?micron, low radiation dose CT scanner. This will facilitate and enhance the scientific quality and productivity of numerous NIH-funded research projects. The research programs that will use the new shared instrument seek to better understand cancer biology, the effects of external beam radiation and targeted radionuclide therapy (TRT) on tumor microenvironment, to combine radiation, including TRT, with immunotherapies with the intent of affording durable curative cancer responses accompanied with immune memory induction. The Major Users group consists of R01, P50, UO1, U54, and DOD-funded investigators, while the Minor Users group also includes RO1 and DOD-funded investigators who request this instrument to achieve their specific aims. Exceptional departmental and institutional support (providing 40% of the purchase price) and outstanding technical expertise assure that the requested equipment will be operable immediately and highly productive at UW for many years to come.

Public health relevance
PROJECT NARRATIVE Single Photon Emission Computed Tomography/Computed Tomography (SPECT/CT) is becoming an increasingly important imaging modality in the use of molecularly targeted radionuclide therapy (TRT) of cancer. The role of the UW Small Animal Imaging and Radiotherapy Facility (SAIRF) recently expanded to include radiotherapy due to a recent influx of grants in this approach to cancer treatment. This proposal is intended to purchase a state-of-the-art high resolution microSPECT/CT scanner, the first such scanner in the State of Wisconsin, as a shared resource for NIH and other federally funded researchers at UW to improve the quality and productivity of their research programs.